Using Implementation Science to Enhance HIV Prevention for Young Men who have Sex with Men

PROJECT SUMMARY/ABSTRACT
Background: Young men who have sex with men (YMSM) bear a disproportionate burden of HIV incidence in
the U.S. Though pre-exposure prophylaxis (PrEP) use is increasing among YMSM, dropout from care is high,
and YMSM are more likely than older MSM to contract HIV after discontinuing PrEP. CDC recommends
motivational interviewing (MI) and personalized health education as part of PrEP care, and these evidence-
based practices are promising for increasing retention in care. Providers lack sufficient time to implement them.
Implementation research is needed to investigate how to facilitate their delivery in diverse clinic settings.
Present Study: The proposed mentored patient-oriented career development award (K23) project will use
implementation science methods to deliver and evaluate an enhanced care intervention, HIV Prevention Plus
Care (HP+ Care), for YMSM starting PrEP in two clinics. HP+ Care will include MI and personalized health
education to promote retention in care and use of PrEP and other prevention methods. Specific aims are: (1)
using the integrated Promoting Action on Research Implementation in Health Services (i-PARIHS) framework,
investigate factors influencing implementation of HP+ care for YMSM in the constructs of the recipients (staff),
their context (clinics), and the innovation (MI and personalized health education); (2) using Aim 1 data, identify
appropriate Expert Recommendations in Implementing Change (ERIC) implementation strategies to facilitate
delivery of HP+ Care in two clinics; and (3) conduct a trial of HP+ Care in two clinics to assess feasibility,
acceptability, and appropriateness.
Candidate: Andrew Barnett, Ph.D., is a clinical psychology postdoctoral fellow at the Alpert Medical School of
Brown University whose research focuses on addressing health disparities, including HIV, among sexual and
gender minority adolescents and young adults.
Mentoring: The primary mentor, Dr. Larry Brown, is an expert in implementing evidence-based practices to
prevent HIV and enhance HIV care, and three co-mentors have complementary expertise in rigorous
quantitative analysis methods (Dr. Barker); HIV prevention and PrEP engagement in clinic settings (Dr. Chan);
and applying implementation science methods to improve delivery of evidence-based practices in healthcare
(Dr. Elwy). The mentors also each have extensive experience guiding early career researchers.
Training: Training activities will advance the following goals: (1) gain experience in conducting implementation
science investigations to prevent HIV in healthcare settings; (2) expand knowledge of novel biomedical HIV
prevention approaches, including PrEP on-demand, long-acting injectable PrEP, and other modalities currently
under development; (3) gain expertise in methods for quantitative analysis of clustered data, including
hierarchical linear modeling; and (4) advance professional development, research ethics, and grants
management skills. Training will prepare the candidate to conduct NIH-funded independent investigations.

Public health relevance
PROJECT NARRATIVE More than three out of four new HIV infections among young adults in the United States occur among young men who have sex with men (YMSM). Although pre-exposure prophylaxis (PrEP) is highly effective in preventing HIV, evidence indicates that many YMSM who initiate PrEP stop taking it and continue to engage in HIV risk behaviors. We will use implementation science to facilitate delivery of the CDC-recommended evidence-based practices motivational interviewing and personalized health education in two clinics providing PrEP services to increase retention in care and use of PrEP and other HIV prevention methods among YMSM.